African Association for Health Professions Education and Research

7. PROJECT SUMMARY/ABSTRACT
This R25 grant application seeks support for strengthening of an indigenous inter-professional
Association, The African Forum for Research and Education for Health (AFREhealth), through
building squarely upon the highly productive experience and achievements of the Medical
Education Partnership Initiative (MEPI) and Nursing Education Partnership Initiative (NEPI).
AFREhealth has potential to catalyze the formation of a strong, stable, and sustainable Pan-
African inter-professional movement. AFREhealth is uniquely positioned to become a high-impact
African health association at the forefront of improving health and lives among all Africans,
including lasting impact in the fight against HIV/AIDS. Novel, innovative approaches are required
to solve Africa’s complex health challenges of today and tomorrow. MEPI and NEPI programs
were started by PEPFAR, NIH, and HRSA in the fight against HIV/AIDS to address the
overwhelming shortage of health care professionals in Africa, focusing primarily on physicians
and nurses. Our proposed Makerere-led, AFREhealth-centered program builds directly on the
strong success of MEPI and NEPI, through carrying forward momentum generated and ensuring
that we, as Africans, assume leadership and ownership of the need to build a strong, skilled health
workforce in our countries and develop effective, efficient systems to deliver quality health
services – ones that ensure both access and equity, and are informed by relevant, rigorous
research. Africa’s health challenges are complex and demand effective collaboration across
professions, contrary to often unilateral, intra-profession efforts. A strong, sustainable
AFREhealth will scale up best practices and innovations, mobilize and engage all health
professions across Anglophone, Francophone and Lusaphone sub-Saharan African countries.
AFREhealth will become the leader and go-to partner to share ideas opportunities, and best
practices for teaching and research, serving as a lead innovator in Africa’s health professional
education and south-south collaboration. Our program design reflects a philosophy of
sustainability, strong governance, and leadership, drawing upon a strong leadership team and
advisory committee, faculty, and participants – thought leaders spanning all health professions
and regions in sub-Saharan Africa. AFREhealth will leverage this project to engage other funders,
national governments, foundations, and private sector to secure complementary investments in
health professions education, research, and health system strengthening. This program will result
in a strong, sustainable AFREhealth, whose achievements will make measurable contributions to
Africans living longer, healthier lives.

Public health relevance
8. PROJECT NARRATIVE This R25 grant application seeks to support establishment of a strong, indigenous inter- professional Association, The African Forum for Research and Education for Health (AFREhealth), through building squarely upon the highly productive experience and achievements of 32 MEPI and 22 NEPI institutions. These two programs have been widely acknowledged for their success in advancing health professional education and strengthening research capacity in 18 African countries and initiating the formation of AFREhealth in 2016. The proposed program seeks to further develop AFREhealth as a strong, transformative, and sustainable association to serve as a leader and convener for scaling up south-south networking and collaboration across the continent to address the daunting health workforce challenges through innovative inter-professions education and research.